Core E: Biostatistics Core

The primary objective of the Biostatistics Core in this P01 is to facilitate the understanding of the biology of melanomas and the development of novel strategies for melanoma treatment based on the most stringent and highest quality of statistical data analyses and inferences. The Biostatistics Core is well organized and equipped to achieve this goal. This Core will provide expertise on experimental design and critical analytical services to Investigators that are tailored to each project and provided in a timely and cost-effective manner. The biostatisticians in this Core will meet regularly with project investigators to develop analytic strategies, assess the statistical needs for each particular project on an ongoing basis, and to modify analysis plans as the research evolves. Since many elements of the statistical analysis plans will be specific to a particular study, each project will benefit from the centralized resource, including individuals who can provide expertise in study design, biostatistics methodology and specialized data analysis techniques and who have had significant experience in solving statistical issues in biological cancer research. This level of collaboration between Core biostatisticians and project Investigators will ensure that the quality and validity of each research project will be of the highest degree. In addition to the statistical services provided to each project, this Core is the essential centralized resource to integrate the data across all projects in this program and synthesize study findings. Using state of the art statistical techniques combined with high-throughput data garnered from each project, the Core will provide a clear and complete view of the associations between studied inhibitors and genotypes, and provide quantitative assessment regarding the development of novel strategies of melanoma treatment in this P01

Public health relevance
This Core is pivotal to ensure that the experimental design and data analyses within the Projects are done in a rigorous, integrated fashion, and to forge new directions in the translational components of the Program Project. This Core has a wealth of experience in cancer research that is used by the Program Project. The quantitative data analyses done by the Core allow us to better understand the associations between the studied inhibitors and genotypes of melanoma, as well as mechanisms of various combination therapies.